ANCHR Admin Core

PROJECT SUMMARY/ABSTRACT – Admin Core
The Alaska Native Center for Health Research (ANCHR) Administrative Core is designed to ensure the success of the overall phase 1 Center at the Alaska Native Tribal Health Consortium (ANTHC). The overall goals of the ANCHR are to develop a cadre of investigators in Alaska engaged in research to address health issues in Alaska Native tribes; expand the capacity for health research in Alaska; and encourage the recruitment of investigators into health research careers at ANTHC and other organizations in Alaska. The ANCHR consists of multiple components, including a Research Core and three individual research projects, as well as the Administrative Core. An Advisory Committee will oversee the ANCHR, including a multidisciplinary group of internal and external experts with a spectrum of interests that align with our Center’s priorities and values. Dr. Thomas is responsible for overseeing the Center as PI, and the Administrative Core is led by Dr. Ferucci. The specific aims of the Administrative Core are to: 1) Provide scientific, administrative, and fiscal support and oversight to all components of the Center; 2) Develop and implement comprehensive training to build the research skills and knowledge essential for the success of current and potential research project leads (RPLs), mentors, and the Center’s research community; 3) Coordinate with the Advisory Committee to obtain regular input on the Center, including at least biannual review of the Center's progress, guidance on recruitment of new RPLs, and review and selection of replacement research projects; and 4) Evaluate and monitor all Center activities, including RPL development and mentoring, according to the proposed timeline and evaluation plan. Our long-term goal is to strengthen ANTHC and Alaska’s research capacity to address health issues among Alaska Native tribes, ultimately to improve the health of the population in alignment with ANTHC’s vision that “Alaska Native people are the healthiest people in the world.” The proposed ANCHR has the potential to significantly improve the capacity of ANTHC and other organizations to conduct research that will improve the health of Alaska Native tribes and improve health in Alaska. Having a tribal health organization lead this Center is innovative and makes the ANCHR well-poised to address health issues in a tribally driven manner.